CONFERENCE PROGRAM FOR YOUNG MINORITY SCIENTISTS

The long term goal of this project is to increase the numbers of active neuroscientist who are from minority groups currently underrepresented in the field. The following Specific Aims are to be accomplished: 1. To bring underrepresented minority neuroscientist and/or neuroscientists aspirants to an Annual Meeting of the Society For Neuroscience where they will be: a. Exposed to recent developments in neuroscience in particular; b. Socialized to mainstream science in general and neuroscience in particular; c. Presented with a broad array of research and career opportunities in neuroscience. 2. To provide formal instruction in professional development to a select group of underrepresented young minority neuroscientist and/or neuroscience aspirants.